Mechanisms of adaptation and resistance to emerging therapies for lung cancer

PROJECT SUMMARY/ABSTRACT
Mutations in the KRAS GTPase are some of the most frequent gain-of-function alterations in cancer. KRAS
mutations are found in 25% of patients with lung cancer and nearly half of these involve a G12C substitution.
Lung cancer is the leading cause of cancer related mortality and, considering that more than 250,000 people
are diagnosed each year with lung cancer in the US, developing therapeutic strategies that directly targeting
KRAS oncoprotein is of paramount importance. The discovery of inhibitors that selectively target KRAS G12C
has been one of the most exciting recent developments in precision oncology. We previously showed that the
inhibitors trap the oncoprotein in an inactive (GDP-bound) state by blocking its reactivation by nucleotide
exchange and that such inhibition requires the breakdown of GTP by mutant KRAS in cancer cells. Inactive
state selective KRAS G12C inhibitors (e.g., sotorasib and adagrasib) have a 37-43% objective response rate
(ORR) and a 6-8 month median progression free survival (PFS) in patients with lung cancer. Sotorasib was
approved by the food and drug administration (FDA) as a second line treatment in patients with KRAS G12C-
mutant lung cancer. Despite these early successes more work is needed if we are to dramatically affect the
survival of patients with KRAS mutant cancer. The current proposal seeks to identify factors responsible for
modulating drug adaptation and resistance in patients and to identify improved KRAS-directed therapeutic
approaches. The first part of the proposal builds on our preclinical work showing that isogenic lung cancer cells
bypass G12C inhibition in a non-uniform manner. Our preliminary data suggest this occurs because of the
conformation-specific nature of available G12Ci and the synthesis of new KRAS G12C in some drug-treated
cells. In Aim 1, we will determine the heterogeneity in response and adaptation to treatment with inhibitors
targeting either the active or the inactive conformation of mutant KRAS. The studies will be performed in
parallel in clinical specimens and in patient derived models to ensure robustness and reproducibility. Aim 2
builds on our recent effort to study acquired resistance in patients treated with sotorasib or adagrasib. Here we
will focus on alterations that cause resistance to emerging active state selective drugs, relying initially on
patient-derived models and then on clinical specimens, once these drugs enter clinical testing in late 2022. In
addition, prospective studies with barcoded populations will investigate the clonal interactions that guide the
selection of resistance-causing alterations. In Aim 3 we will study the mechanisms by which the alterations or
phenotypes identified in the preliminary data or in Aims 1 and 2 lead to resistance. The early success of KRAS
G12C inhibitors has inspired the development of additional KRAS inhibitors that are entering clinical trials and
promise to improve the survival and quality of life of patients with KRAS driven cancer. The proposed work will
be of vital importance in maximizing the therapeutic potential of these long-awaited therapies.

Public health relevance
PROJECT NARRATIVE KRAS mutations are found in approximately one fourth of lung cancers, a disease that kills approximately 160,000 people annually in the U.S. The treatment of patients with this molecular subtype of lung cancer remains one the biggest challenges faced by medical oncologists. This proposal will study how patients and patient-derived models respond to emerging inhibitors that directly inactivate mutant KRAS in order to develop effective treatments that prolong survival and improve the quality of life in patients with lung cancer.